Plasmodium vivax in a mobile population in northwestern Kenya

ABSTRACT
Plasmodium vivax has not traditionally been considered in malaria elimination strategies across Africa, due to
the assumption that its transmission cannot be supported in the predominantly Duffy-negative population.
Nevertheless, there is growing evidence that P.vivax is present across the continent and Duffy-negative
individuals can contribute to onward transmission. Data from other elimination settings in Southeast Asia show
that P.vivax becomes more prominent as P.falciparum (the dominant malaria species in Africa) declines. This
poses a major threat to malaria elimination in Africa, particularly since surveillance and control strategies
across the continent are almost exclusively focused on P.falciparum. Mobile pastoralist communities in
northwestern Kenya may be especially susceptible to P.vivax infection due to their proximity to and seasonal
contact with neighboring Ethiopia, where both P.vivax and Duffy-positive populations are present. They have
been moving to and from Ethiopia with their herds for hundreds of years, thus it is possible that 1) these
northwestern Kenyan communities harbor higher levels of Duffy antigen than most Kenyan populations and 2)
their regular movements represent opportunities for importing P.vivax. Therefore, the pastoralist communities
in northwestern Kenya represent a high-value surveillance population for monitoring and mitigating the threat
of P.vivax transmission in the region. However, they remain largely outside of routine public health activities
due to their isolated and remote nature, and little is known about their health status or malaria risk. We propose
to leverage samples and data from a recently completed study in nomadic pastoralists in order to quantify the
threat of P.vivax in this specific group and in the region more broadly. The parent study confirmed elevated risk
of P.falciparum infection in those traveling with the herds compared to those who remain in the settlement. In
addition, we have already identified several P.vivax infections, but the extent and relationship to Duffy antigen
are still unknown. In the proposed work, we will first screen >1500 samples for P.vivax infection and describe
the prevalence of P.vivax for the first time in this unique population. Then, we will work with Community Health
Workers to obtain permission to test participant samples for expression of the Duffy receptor. This new
information, coupled with the rich data associated with each sample, will allow us to assess the risk of
emerging P.vivax in this group, determine the value of enhanced surveillance and targeted control, and
recommend criteria for identifying critical surveillance populations as Kenya moves towards malaria
elimination. The findings from this study would have broad application, informing malaria surveillance and
control strategies in Turkana, Kenya, and areas across SSA where P.vivax may have an increasing impact as
P.falciparum is controlled.

Public health relevance
PROJECT NARRATIVE Remote nomadic groups in northwestern Kenya near the border to Plasmodium vivax-endemic Ethiopia are particularly at risk of contracting P. vivax, but remain largely outside of public health surveillance or programming. We will leverage samples and data from a recent study of malaria in nomadic pastoralists to try to understand the potential for emerging P. vivax in this population and the region, and determine whether this group represents an important sentinel surveillance population for P. vivax emergence and control. Findings from this study will generate evidence to guide Kenya’s National Malaria Control Programme and similar regions of Sub-Saharan Africa as they confront the possibility of growing endemic P. vivax transmission.